TNF deficiency induces breach of B cell tolerance via altering B cell regulatory signals

PROJECT SUMMARY
The induction of autoantibody and autoimmunity in patients treated with TNF inhibitors (TNFi) is well-known;
however, the mechanism by which TNFi induce breach of B cell tolerance is yet to be determined. In humans,
TNFi affect B and T cell homeostasis via disruption of germinal center (GC) formation which is pivotal for high
affinity antigen-specific antibody production and negative selection of autoreactive B cells. Similarly, in mice,
TNF signaling deficiency prevents GC formation, induces TFH and CD4+IL-17 producing cell expansion, and
alters autoantibody profiles. This small focused study proposes that TNF deficiency, together with a second
inducing stimulus, compromises B cell selection via reduction of negative B cell signaling and enhancement of
T effector cell activities. To test this hypothesis, the first aim utilizes: 1) TNF deficient mice of 2 different
backgrounds, autoreactive Sle1.TNF-/- mice induced with a TLR9 agonist and NZM2328.TNFR1/2 double
deficient mice, and 2) Sle1.TNF-/-.Yaa, in which male mice over express TLR7, to determine the mechanism for
the signaling defect of activated B cells that alters B cell selection via either GC and/or extrafollicular pathway.
The second aim will address similar questions in TNFi treated patients by identifying changes in CD22 binding
dynamics which thereby affect BCR signaling in autoreactive B cells. This aim is made possible due to the
development of the novel ANA reagent that identify enriched autoreactive B cells in both humans and mice. The
results from this study will elucidate the effects of TNFi on regulating B cell tolerance and improve our
understanding of how the immune system regulates B cell tolerance in GC and extrafollicular pathways.

Public health relevance
Project Narrative TNF inhibitors (TNFi) are biological anti-inflammatory drugs that are used worldwide as first or second-line treatment for chronic autoimmune diseases; however, 15-30% of patients treated with TNFi develop anti-nuclear antibodies within 6 months of starting treatment and 0.2-1% develop clinical lupus. This project will use both mouse models and a cohort of human patients starting on TNFi to determine whether TNF deficiency influences B cell selection via altering expression and/or function of regulatory signaling molecules. These studies should enhance our knowledge of regulation of tolerance during immune responses and may help to improve selection of patients for safe use of TNFi treatment.